ROLE OF IMMUNE ACTIVATION IN SIV PATHOGENESIS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The objective of this study are to identify 1) the role of regulatory T cells in SIV pathogenesis, 2) In vivo expansion of regulatory T cells and its effect on SIV pathogenesis, and 3) Age-dependent differences in Treg frequencies and function.